Kynurenine Pathway Regulation of CNS Senescence in Alzheimer's Disease Pathology

This is a NOT-AG-22-025 Administrative Supplement application based on work derived from our Parent non-
Alzheimer’s disease (AD) award R01 (AG067510-01A1), that has potential to provide preliminary data justifying
a separate AD focused R01 submission. We have recently identified, and extensively published, on a novel age-
related mechanism that drives a disruption in bone homeostasis that appears to also apply to AD. Specifically,
metabolites of the diet derived essential amino acid tryptophan (TRP) as part of the Kynurenine (KYN) Pathway
(KP) are generated by oxidative injury and inflammatory factors. We have shown that the increased levels of
KYN and other KP metabolites in vitro, and in vivo, block autophagy, and induce senescence in stem cells,
monocytes, and osteogenic/muscle cells disrupting cell and tissue function. Senescence is beginning to be
recognized as a key effector in AD pathogenesis. Critically, we have preliminary data showing that ROS and
inflammatory factors drive senescence in astrocytes and microglial cells, and importantly that KYN negatively
affects human monocyte derived microglial cells including the induction of senescence markers. Senescence
and the aging-phenotype tissue disfunction in musculoskeletal tissue can be rescued by blocking the signaling
pathway for the primary KP metabolite receptor, the Aryl Hydrocarbon Receptor (AhR), or by inhibiting key KP
enzymes such as indoleamine 2,3-dioxygenase (IDO) that generates KYN, or kynurenine monooxidase (KMO)
that generates other CNS targeting KP metabolites. We propose to determine applicability of targeting the KP
driven pathogenic senescence in AD, in part initially using 5xFAD model that rapidly (4-5 months) develops AD
pathology. Importantly, there are pharmacological inhibitors to AhR, IDO-1 and KMO in clinical trials supporting
rapid assessment of potential novel AD therapeutic approaches. Hypothesis: Aging-associated oxidative
stress/inflammation leads to KP mediated accumulation of senescent cells in the brain, which promote
the pathogenesis and progression of AD via exacerbating amyloid beta (Aβ)-induced neurotoxicity and
tau pathology, and/or directly via senescent CNS cell dysfunction. Preliminary data from this proposal
demonstrating feasibility of key technical and conceptual approaches will support a successful AD R01
application. Aim 1. Demonstrate the feasibility of a large scale CyTOFF assessment of senescent markers
co-localized with specific cell type markers. This is a key technology to identify specific patterns of KP
mediated inhibition of autophagy together with the induction and spread of senescence in CNS glial, endothelial
and neuronal cells or its reversal with KP enzyme inhibition. Aim2. Assessment of KP driven senescence in
an AD mouse model (5xFAD) that can be used in a single year project. 5xFAD and controls will be treated
with a subset of KP metabolites or with AhR, IDO-1 or KMO inhibitors. This will establish if age and
ROS/inflammation generated KP metabolites mediate senescence and AD pathologies, and if inhibition of their
production or signaling blocks AD progression, leading to novel near-term therapeutics.

Public health relevance
This is a NOT-AG-22-025 Administrative Supplement application based on work derived from our Parent non- Alzheimer’s disease (AD) award R01 (AG067510-01A1), with the goal of this application to provide preliminary data which will allow us to submit an AD focused R01 to be responsive to the NIH interest in understanding novel disease mechanisms driving AD and AD Related Disorders. Under our Parent R01 we have recently identified, and extensively published, on a novel age-related mechanism that drives a disruption in bone homeostasis leading to osteoporosis that we believe is also relevant to AD progression and may provide new innovative therapeutic approaches.